Harvard Summer Research Program in Kidney Medicine

This is a renewal application for the Harvard Summer Research Program in Kidney Medicine (HSRPKM)
which provides a hands-on experience for talented undergraduate students to establish and build upon
their interest in kidney and urology research. The HSRPKM was initiated and funded in 2014. Over the last
10 years we have enrolled 118 students from 67 colleges/universities in 32 states. Fifty-five percent were
women and 20% were members of groups underrepresented in medicine (URiM). In the past five years
our URiM enrollment has increased to 27% and our female enrollment has increased to 59%. The average
GPA of the students over the past 10 years is 3.89. Our program is built around providing students with an
intensive, hypothesis-driven, mentored research experience. Each student’s project is mentored by an
investigator on the Harvard Medical School faculty at Brigham and Women’s Hospital, Beth Israel
Deaconess Medical Center, Boston Children’s Hospital or Massachusetts General Hospital. A site director
at each hospital helps place students with the appropriate mentor. We have a diverse group of 30 Program
Faculty involved in research and career mentoring, retention, and assessment. In addition to their daily
research, students participate in a weekly core curriculum to introduce them to the breadth of kidney
biology in health and disease. This includes: 1) an introduction to the principles of renal physiology; 2) a
renal gross pathology session with autopsy specimens; 3) training for and performing a community
screening for kidney disease; 4) a visit to an outpatient dialysis center to appreciate the impact of kidney
disease and experience this current treatment approach for patients with kidney failure; 5) an opportunity
to observe the clinical work of a nephrologist or urologist; and 6) additional sessions on patient perspectives
and the contributions of research in the biotech/pharma industry to new therapeutic approaches. Students
present their work locally and then nationally at the NIDDK-KUH Summer Research symposium. There
are close ties with the Kidney Disease and Awareness Program (KDSAP). HSRPKM alumni have started
12 KDSAP chapters (52% of the current chapters) which enable longitudinal experiences with, and
increased peer awareness of, kidney health and disease. A year-round program of mentorship, career
development sessions, and networking helps sustain alumni interest in Nephrology and Urology. The
Program Directors have assembled an Advisory Committee to oversee the program and judge its
effectiveness. They have also assembled a Mentorship and Retention Faculty group of URiM faculty to
help develop and implement recruitment and retention strategies, especially as they relate to trainees from
backgrounds URiM. An Assessment Committee will continue to expand evaluative approaches to optimize
the trainee experience and determine the effectiveness of the HSRPKM in achieving the NIDDK-KUH
Institute’s goals.

Public health relevance
The Harvard Summer Research Program in Kidney Medicine (HSRPKM) will recruit and develop the next generation of kidney medicine and urology leaders of diverse backgrounds. The Program is structured around each student’s summer 9-week research experience at one of four Harvard teaching hospitals (Brigham and Women’s Hospital, Massachusetts General Hospital, Beth Israel Deaconess Medical Center, or Boston Children’s Hospital), which is complemented by a core curriculum that teaches kidney physiology and exposes students to the perspectives of people with kidney disease in the community. To provide longer term career development interactions, HSRPKM will keep these talented young scientists engaged with kidney medicine after their summer experience by developing year-round career development and networking events.